Influences of viewing geometry on neural computations of motion and depth

Vision is active—we move our eyes to acquire information and to track objects of interest.
However, eye movements have visual consequences; for example, when we smoothly move
our eyes to pursue an object of interest, this adds components of motion to the retinal image.
These visual consequences of eye movements must be compensated to judge how objects
move in the world. The conventional view is that compensation for smooth pursuit eye
movements can be achieved by subtracting a vector (equal and opposite to the eye movement)
from retinal image velocity. We demonstrate that this conventional view has limited applicability,
and that even a simple combination of eye translation and rotation has visual consequences
that cannot be compensated by a vector subtraction. Crucially, this means that the brain needs
to infer the viewing geometry (defined here as how the eye translates and rotates relative to the
scene) and then perform different computations to estimate the motion and depth of objects
during pursuit eye movements, depending on the viewing geometry. We develop a theoretical
framework that predicts how perception of object motion and depth should depend on viewing
geometry. In Aim #1, we use human psychophysics to test our theoretical predictions.
Preliminary data show the perceived motion and depth have perceptual biases that depend
strongly on viewing geometry, as predicted by our theory, even while the retinal velocity of the
judged object remains fixed. These biases occur automatically, without training or feedback. In
Aim #2, we test whether neural activity in passively fixating monkeys is influenced by viewing
geometry (without training) in ways that can account for perceptual biases. In Aim #3, we
measure both behavioral and neural effects of manipulating viewing geometry to assess
whether neural modulations in different visual areas (MT, MSTl, and VPS) can account for the
observed perceptual biases. Our strong preliminary data suggest that we will make important
advances in understanding how inferred viewing geometry interacts with neural computations of
motion and depth. The proposed research is directly relevant to the research priorities of the
Strabismus, Amplyopia, and Visual Processing program at the National Eye Institute.

Public health relevance
We propose a theory-driven set of behavioral and neurophysiological experiments that address the novel question of how the brain infers viewing geometry from optic flow and then uses that information to compute the motion and depth of objects. Deficits in perceiving self-motion are among the earliest consequences of Alzheimer's disease, and can substantially impact patients' lives. By understanding how optic flow processing is linked to motion and depth perception, our work will reveal novel neural mechanisms by which Alzheimer’s disease may impair common visually-guided behaviors.